Retinal Patterning During Eye Development

The function of the visual system is to form images in the brain. Correct photoreceptor neuron specification,
patterning and morphogenesis within the retina are prerequisites for correct retinotopic axonal projections and
thus image formation. The Drosophila eye serves as an excellent paradigm for many aspects of eye
development, retinal biology, and disease. It is composed of a stereo-typed array of hundreds of ommatidia, or
unit eyes/facets, each containing a precise arrangement of 8 photoreceptor neurons, R-cells. Establishment of
their fates and their ordered arrangement requires an interplay of several signaling pathways, which have
conserved similar functions during mammalian eye development. Precise retinal arrangement and
morphogenesis requires a distinction of two subtypes of photoreceptors, R3 and R4, via an exquisite regulation
and interplay of canonical Wnt/b-catenin signaling, the Wnt-Fz/planar cell polarity (PCP) pathway, and Notch
(N)-signaling. Wnt/b-catenin signaling sets up the D/V-axis and limits eye development to a specific number of
ommatidia. Wnt/Fz-PCP signaling interprets the D/V-axis information to induce R3 vs R4 neurons, during
which process it has to both activate N-signaling in neighboring cells (to induce R4), and simultaneously inhibit
N-activity in R3. Thus, a highly regulated Wnt/Fz and N-pathway crosstalk determines photoreceptor patterning
and morphogenesis of the retina. Our prelim. data identified a novel inhibitory mechanism between Wnt and N-
signaling at the level of Dsh/Dvl and the N-dependent transcription factor Su(H), CSL in mammals. Through a
genome wide genetic screen, we have also uncovered a set of novel factors that modulate the function of Fz-
Dsh/PCP signaling. Furthermore, the scope of this application addresses the cell biology of retinal morphology
downstream of the PCP and N-pathways. The Specific Aims are: (1) To dissect an inhibitory cross-talk
between the Wnt/Fz-Dsh and Notch/Su(H)-signaling pathways and the associated effects on R3/R4
specification; and (2) To use live imaging protocols, which we recently established, to get insight on how the
kinases Abl (acting downstream of N-signaling), and Src64 and Pak1/3 (acting downstream of core Wnt/PCP
signaling) regulate retinal morphogenesis and associated biophysical properties of cell adhesion and tissue
fluidity. These Aims are well integrated and based on exciting hypotheses and preliminary data, including the
mechanism of Wnt/Fz-pathway inhibition of Notch-signaling as mediated by Dsh/Dvl (Aim 1), and analyses of
several kinases in retinal morphogenesis and cell adhesion as effectors of the signaling pathways studied in
Aim 1 (Aim 2). A combination of in vivo studies, genetics, cell culture and biochemical experiments will be
utilized together with newly developed live imaging protocols and molecular markers to achieve these goals. In
the human eye, Wnt-Fz and Notch signaling are associated with many diseases and several components are
associated with congenital ciliopathies affecting retinal function. Thus, the information acquired here will
advance our understanding of retinal biology and will also be of medical relevance in disease areas.

Public health relevance
Correct photoreceptor neuron specification, patterning, and morphogenesis in the retina are essential for vision. Understanding the Wnt/Frizzled (Fz)-PCP and Notch-signaling pathway read-outs and their interactions in this context has important implications in both vision research and other diseases, including ciliopathies, ranging from retinal degeneration, mental retardation and cancer to angiogenesis defects. This application addresses the regulation of these pathways in photoreceptor specification and retinal patterning.